New analytic methods for new data sources

Project II: New Analytic Methods for New Data Sources develops and tests statistical approaches for interpreting participatory surveillance and mobile phone data for parameterization and testing of transmission-dynamic models, uses hydrological modeling to build risk maps for malaria, and develops the statistical theory of negative controls.